Investigating human cis-regulatory evolution with hybrid iPS cells

Project Summary
Despite a great deal of research, we have discovered surprisingly little about the genetic
basis of uniquely human traits—largely due to the ethical and practical considerations that
severely limit comparisons between humans and other primates. To advance this field, we
have integrated two effective approaches for studying evolution: induced pluripotent stem
(iPS) cells, and interspecific hybrids. iPS cells can be differentiated into a wide range of
cell types in vitro, circumventing many limitations of primate research, while measurement
of allele-specific gene expression in hybrids allows cis-regulatory divergence and gene
expression adaptations to be mapped genome-wide. To combine these approaches, we
have recently generated human/chimpanzee hybrid iPS cells. We propose to characterize
this powerful resource with RNA-seq and cellular phenotyping in diverse cell types,
including cardiomyocytes, motor neurons, hepatocytes, pancreatic progenitors, skeletal muscle,
retinal pigmented epithelium, and skin organoids that include dermis/epidermis, adipose,
cartilage, hair follicles, and more. Our goal is to discover and experimentally validate genes and
genetic variants that have contributed to the evolutionary origin of our species.

Public health relevance
Narrative The main goal of our project is to improve our understanding of the genetic basis of human- specific phenotypes. This may eventually lead to deeper knowledge of the origins and etiologies of human-specific diseases such as epithelial cancers, acne, autism, schizophrenia, and Alzheimer’s disease.